In vivo assessment of the mitochondrial complex I in subjects with schizophrenia

Project Summary/Abstract
In schizophrenia (SCH), impairment in cognitive function, a core element of this illness, is observed prior to the
onset of psychosis and has been tied to long-term outcomes. One suggested pathophysiologic mechanism for
the cognitive deficits in SCH is disturbances in the ability of neurons to engage in synchronous oscillatory activity,
a phenomenon thought to be essential for normal cognitive function. Increased cognitive load normally results
in gamma range (30 – 100 Hz) oscillatory activity in the dorsolateral prefrontal cortex (DLPFC) but the generation
of gamma activity is impaired in subjects with SCH. Gamma oscillatory activity is dependent on networks of fast-
spiking, parvalbumin positive (PV+), GABA interneurons (IN) which synchronize pyramidal cell firing. Fast-
spiking PV IN are highly energy dependent and, in turn, highly dependent on mitochondrial function. Given the
energy requirements of the PV IN, abnormalities in brain energetics and/or mitochondrial function may play
significant role in the cognitive symptoms of SCH. Given that the generation of gamma oscillatory activity relies
on cellular energy production it is highly sensitive to disruptions in mitochondrial function. Mitochondria generate
the majority of energy in the brain producing 95% of cellular adenosine triphosphate (ATP) through oxidative
phosphorylation (OxPhos) via the electron transport chain (ETC). An impairment in mitochondrial function will
result in reduced energy generation and a shift from OxPhos to the pathway of aerobic glycolysis (AG; lactate
production in the presence of O2), with a resulting increase of lactate and reduction in pH. The first enzyme in
the ETC, mitochondrial complex I (MC-I), is the rate limiting step in neuronal oxygen utilization. Dysfunction of
MC-I in SCH is observed in post mortem studies as well as in peripheral blood cells. In vivo measures of brain
OxPhos using phosphorus magnetic resonance spectroscopy (31P-MRS) provide direct measures of ATP,
phosphocreatine (PCr) and inorganic phosphorus (Pi) and suggest a deficit of OxPhos in SCH, although no clear
pattern has emerged. The current application seeks to examine in vivo brain energetics in SCH by utilizing
[18F]BCPP-EF positron emission tomography (PET) to establish MC-I distribution and 31P-MRS to measure more
detailed brain energetics (ATP, PCr, Pi). 10 medication-free individuals with SCH and 10 age and sex matched
HC will participate in this study. [18F]BCPP-EF standardized uptake value ratio (SUVR-1) will be measured in
both groups in the DLPFC. We will test whether lower DLPFC SUVR-1 in SCH will predict impairment on the
Brief Assessment of Cognitive Function in Schizophrenia. In the same subjects, at the same time, PCr/ATP and
Pi/ATP will be measured with 31P-MRS and correlated with [18F]BCPP-EF SUVR-1. The data from this application
will provide a more comprehensive understanding of MC-I in SCH and its relationship to the shift in brain
energetics to AG. These results will lay the groundwork for understanding whether mitochondrial OxPhos is
impaired in SCH and exacerbates the cognitive impairments observed in this illness. The ultimate goal is that a
deeper understanding of brain energetics in SCH will lead to the development of improved therapeutics.

Public health relevance
Project Narrative Abnormalities in brain energetics appear to play a significant role in the pathophysiology schizophrenia. We will apply novel brain imaging techniques to measure elements of brain energetics including the mitochondrial complex I, a key element in oxidative phosphorylation, and the metabolites involved in oxidative phosphorylation, including adenosine triphosphate, inorganic phosphate, and phosphocreatine. The data from this application will provide a fuller picture of alterations in brain energetic processes involved in schizophrenia with the ultimate goal that this deeper understanding will lead to the development of improved therapeutics for this illness.